AAV therapies for TNNT2-associated cardiac disorders

PROJECT SUMMARY
Of the 7 million individuals in The US with heart failure (HF), ~1 in 500 have hypertrophic cardiomyopathy (HCM),
while ~1 in 200 suffer from dilated cardiomyopathy (DCM). Large-scale genetic sequencing studies have shown
that both HCM and DCM can be caused by pathogenic or likely-pathogenic (P/LP) genetic variants in the TNNT2
gene. This gene encodes cardiac troponin T, a regulatory protein in the sarcomere essential for the heart’s
contractile function. ~115,000 individuals in the US with HCM or DCM have been identified to carry P/LP TNNT2
variants. These genetic variants disrupt the sarcomere’s calcium (Ca2+) sensitivity, causing hypercontractility in
HCM or hypocontractility for DCM. The severity of these effects depends on the ratio of mutant TNNT2 to wild-
type TNNT2 protein. Despite extensive research on the impact of P/LP TNNT2 variants, no treatments currently
target this gene. Attempts to use small molecule drugs to address these genetic effects have been unsuccessful.
To overcome this challenge, we engineered first generation adeno-associated viruses (AAVs) capable of
delivering wild-type TNNT2 to cardiomyocytes. In pilot studies conducted in mice, these AAVs successfully
prevented DCM in vivo for the first time. Additionally, the simultaneous knockdown of mutant mRNA significantly
improved outcomes. To move toward clinical application, we propose optimizing and screening next-generation
AAVs to identify a lead therapeutic candidate suitable for an investigational new drug (IND) application. This
project follows a milestone-driven approach. In the R61 Phase: 1) AAV development and validation—to identify
validate and screen promising AAV candidates; 2) micro RNA (miR) targeting—to design a miR to selectively
suppress mutant TNNT2 mRNA; 3) preliminary efficacy testing—conduct human cell-based assays to evaluate
efficacy and establish dose-response curves, and to utilize human 3D cardiac microtissue models of HCM and
DCM to simulate real-life conditions and assess therapeutic effects; and 4) in vivo mouse studies—to perform
short-term efficacy and dose-response studies using a mouse DCM model, while simultaneously identifying
serum biomarkers to aid in the prediction of therapeutic response in vivo. R33 Phase progression will require
identifying at least one AAV that restores normal contractile function with minimal toxicity. Key R33 activities
include: 1) preclinical testing in DCM mice using a prevention and treatment study design; 2) comprehensive
dose-response analyses across cardiac structure and function (echocardiography), single cardiomyocyte
physiology and Ca2+ analyses (IonOptix); transcriptomic profiling (RNA-seq and qPCR) and serum biomarker
studies (ELISA); and 3) tissue distribution and preliminary toxicity measurements (ddPCR, ELISA and histology).
These studies will support intellectual property, large-animal safety testing, IND applications, and eventually,
Phase I clinical trials in collaboration with our Accelerator Partner (JAX Accelerator), the NHLBI Catalyze
Coordinating Center, and outside consultants. Our ultimate goal is to create the first TNNT2-targeted gene
therapy for cardiomyopathy.

Public health relevance
PROJECT NARRATIVE Pathogenic variants in the cardiac troponin T gene (TNNT2) cause hypertrophic and dilated cardiomyopathies, two disorders that are associated with high rates of heart failure and premature death unless new disease- modifying therapies are developed. Our study will develop an adeno-associated virus therapy that replaces pathogenic TNNT2 with its normal wildtype version by performing efficacy and safety screening in human cardiomyocytes, 3-dimensional microtissues, and genetic mouse models. This research has the potential to discover not only a new therapeutic for cardiomyopathy caused by TNNT2 variants, but a roadmap to develop similar therapies for related genetic forms of heart failure.